Intersectional Stigma Experiences, Pre-exposure Prophylaxis (PrEP), and Other Service Use Among People Who Inject Drugs

Project Summary/Abstract
Pre-exposure prophylaxis (PrEP) can prevent HIV infection among persons who inject drugs (PWID). However,
PrEP use among PWID is low and there have been several recent HIV outbreaks among PWID throughout the
United States. Few studies have focused on PrEP for PWID although many PWID are eligible for PrEP. A
significant barrier to PrEP for PWID is stigma (i.e., social devaluation and discrediting), especially stigma
related to drug use, which can translate into negative healthcare interactions and/or healthcare avoidance as
well as healthcare providers being less willing to prescribe PrEP to PWID. PWID may have multiple
characteristics that could be stigmatized such as drug use, race/ethnicity, sexual identity, gender, and poverty,
as well as stigma attributed to HIV and PrEP. In addition, PWID may experience stigma at the organizational
level (e.g., in healthcare, drug treatment, pharmacies, or syringe exchange programs) or at the structural level
in the form of state policies. It is important to understand how these multiple characteristics create unique
stigma experiences (i.e., intersectional stigma – stigma characteristics that are experienced simultaneously)
among sub-populations of PWID that could affect PrEP and service use. The purpose of this research is to
understand intersectional stigma among PWID and how it affects PrEP and other service use though the
following specific aims: (1) Identify sub-populations of PWID that display different patterns of stigma due to
drug use, race/ethnicity, sexual identity, gender, and poverty; (2) examine associations of patterns of stigma
with PrEP willingness and uptake and other service-related variables over time; (3) evaluate how and if
covariates (sociodemographic variables, HIV and PrEP stigma, and structural stigma by state) moderate
associations of stigma with PrEP use and other service use. The results of this study will inform PrEP
implementation broadly, as well as inform the development of stigma and PrEP interventions tailored to sub-
populations of PWID. The research project is part of a comprehensive training program designed to facilitate
Dr. Walters transition to research independence. Training aims include (1) Building topical expertise in
intersectional stigma experienced by PWID; (2) Develop methodological expertise in latent variable modeling
and effect modification; (3) Gain training in intervention science; (4) Gain expertise in ethical conduct of
research pertaining to HIV prevention among PWID; and (5) Strengthen professional skills for a successful
independent research career.

Public health relevance
Project Narrative People who inject drugs (PWID) are at risk for HIV, and pre-exposure prophylaxis (PrEP) could be an effective means of HIV prevention. PrEP uptake is low among PWID because of numerous barriers, one of which is stigma due to multiple intersecting characteristics such as drug use, race/ ethnicity, sexual identity, gender, poverty, HIV, and PrEP (i.e., intersectional stigma). This study aims to determine the relationship between intersectional stigma and PrEP willingness and uptake, as well as associations with other service use (i.e., healthcare, drug treatment, pharmacies, or syringe exchange programs) over time.